Mechanistic roles of the basement membrane mechanics in cellular morphodynamics and tissue patterning of the pre-gastrulating embryo

Project Summary/Abstract
Establishing proper tissue-level architecture and patterning during early embryogenesis is crucial for a
successful pregnancy. A high rate of mortality seen in human embryos during the first 2-3 weeks post-fertilization
is a major cause of early pregnancy loss, yet the essential cellular, molecular, and mechanical changes remain
poorly defined. During early post-implantation mammalian embryogenesis, an extra-embryonic epithelial layer,
the visceral endoderm, plays an essential role in the symmetry-breaking event that specifies the anterior-
posterior patterning of the epiblast. Specifically, a subset of the visceral endoderm cells, the anterior visceral
endoderm, migrates toward one end of the future anterior-posterior axis to pattern the epiblast. Recent work
from our lab reveals that the embryonic basement membrane plays an essential role in symmetry breaking and
morphogenesis that sets the stage for gastrulation. However, how the extracellular mechanics modulates the
collective cellular dynamics and instructs cell identities for pattern formation remains not known.
Here we propose to determine how the embryonic basement membrane coordinates the collective cell
behaviors and facilitates anterior-posterior specification for pattern formation. First, we will comprehensively map
the cell behaviors of the entire visceral endoderm with imaging approaches and define the role of the basement
membrane in anterior visceral endoderm migration through genetic perturbations in stem cell-derived embryo-
like structures as well as in the natural embryos. Next, we will map the basement membrane mechanics and
apply a single-cell transcriptomics approach to generate in situ cell fate maps of the pre-gastrulating embryos.
We will functionally test how the basement membrane mechanics regulate cell identities by correlating the gene
expression profiles with basement membrane architecture and validate the findings with basement membrane-
perturbed embryos. Finally, we will implement multi-scale mathematical models that integrate cell identities and
cell dynamics with the basement membrane mechanics to uncover mechanisms of pattern formation.
Overall, these experiments will unveil functional roles of the extraembryonic environment in defining the cell
identities of the pre-gastrulation embryos. These findings will inform subsequent studies in my future goals on
the conserved roles of the basement membrane and the extraembryonic tissues in topologically distinct embryos
seen in human. Training during my fellowship period will expand my skillsets toward studying the more complex
biology of mammals and broaden my knowledge on new aspects of developmental biology. The research
environment at California Institute of Technology will further foster interdisciplinary collaborations that allow the
development of novel approaches to investigate early mammalian embryogenesis.

Public health relevance
Project Narrative Establishing proper tissue architecture is crucial for animal development and defects in tissue organization often lead to embryonic lethality and are seen in pathological processes such as in cancer. My proposed work will provide insights on early post-implantation mammalian embryonic development that may help prevention for infertility caused by early pregnancy loss. These mechanisms discovered may also inform cancer prevention and diagnosis by revealing early signs of malignancy, before initiation of the epithelial–mesenchymal transition upon the onset of metastasis.